Impact of vascular apoE in aging and AD

PROJECT SUMMARY (APOE U19: Project 4)
While the major function of apolipoprotein E (apoE) is to mediate the lipid transport, APOE genotype (APOE2,
APOE3 and APOE4) significantly influences cognitive function and Alzheimer’s disease (AD) pathogenesis
through multiple pathways. APOE is associated with not only amyloid-β (Aβ) pathology but also cerebrovascular
function including blood-brain barrier integrity and cerebral blood flow. Given that cerebrovascular disturbance
substantially contributes to cognitive decline in the elderly and that apoE is abundantly expressed in vascular
mural cells (smooth muscle cells and pericytes) as well as astrocytes and microglia in the brain, the overall goal
of Project 4 is to define how APOE genotype in vascular mural cells impacts the molecular mechanisms and
pathways in the development of cerebrovascular dysregulations and cognitive decline during aging and AD. In
Aim 1, we will utilize novel mouse models, in which human APOE2, APOE3, or APOE4 gene is expressed upon
an excision of a loxp-flanked STOP cassette by vascular mural cell specific sm22α promoter driven Cre
expression to determine the effects of vascular mural cell-specific expression of apoE isoforms on
cerebrovascular function and brain cognition during aging. In Aim 2, we will define the impact of apoE isoform
deletion in vascular mural cells on age-related cerebrovascular dysfunction and cognitive decline using novel
APOE knock-in mice, in which murine Apoe is replaced with floxed APOE2, APOE3, or APOE4 gene. By
crossing with sm22α-Cre mice, we will specifically delete individual apoE isoforms in vascular mural cells. In Aim
3, we will examine how vascular-specific expression or deletion of apoE isoforms in conditional mouse models
affects AD-related phenotypes by breeding the vascular mural cell-specific apoE isoform expressing or knockout
mice with amyloid model APP knockin mice (AppNL-F/NL-F). Using those unique mouse models, we will
comprehensively investigate how apoE isoforms in vascular mural cells impact cerebrovascular function, glial
phenotypes, neuroinflammation, neurodegeneration, brain cognition and amyloid pathology at different ages. In
particular, the apoE properties in the mouse models will be analyzed by the Biochemistry and Structural
Modeling Core (Core B). ApoE amounts, oxidation and/or glycation in the mice as well as other AD-rerated fluid
biomarkers will be measured through the Biomarker Core (Core D). While neuropathology in the mice will be
investigated in Neuropathology Core (Core C), a multi-Omics approach including proteomics, metabolomics,
lipidomics and single cell RNA sequencing will be carried out through the Multi-Omics Core (Core F) and
Bioinformatics, Biostatistics, and Data Management Core (Core G) to profile molecular phenotypes in these
mouse models. Together, our innovative study should fill a critical void in our understanding of how apoE
isoforms in cerebrovasculature impact cellular functions and brain homeostasis during aging and AD through
synergistic interaction with Core B-G and comparative mouse model studies by Project 2 and Project 3.